QTL mapping with Collaborative Cross mice defines genes that promote allergic airway inflammation

PROJECT SUMMARY
Allergen-induced asthma is a chronic disease predominantly characterized by dysregulated type 2
inflammation in the lung. While the adaptive immune system has been implicated in asthma pathogenesis for
many years, research over the last decade has recognized that Group 2 innate lymphoid cells (ILC2) are
potent drivers of type 2 inflammation in the lung and major contributors to allergen-exacerbated asthma. ILC2
are similar in function to Th2-polarized CD4+ helper T cells in that they produce Type 2 cytokines like IL-5 and
IL-13, but they lack rearranged antigen receptors and are instead activated predominantly by alarmin
cytokines. While their pro-inflammatory potential and connection to asthma has been established, the precise
mechanisms by which these cells are activated and proliferate in response to aeroallergens are ill defined. I
have utilized the Collaborative Cross recombinant inbred mouse panel to map a quantitative trait locus (QTL)
that associates with the number of lung ILC2, a function of activation and proliferation, in response to airway
challenge with extract from the common environmental allergen Alternaria alternata (Alt Ex). The Collaborative
Cross (CC) is an ambitious, multi-center mouse genetics project created to allow for the investigation of
complex polygenic traits. The panel boasts over 50 recombinant inbred lines created from 8 founder strains (5
lab-derived, 3 wild-caught) that encompass >90% of the known genetic diversity in the Mus musculus species.
I enumerated ILC2 after Alt Ex challenge in 45 unique founder and recombinant CC strains, and I successfully
mapped a novel 0.343 megabase QTL associated with ILC2 number in the lung containing 72 protein coding
genes. The goal of this proposal is to identify and define the precise function of the causative gene or genes
within this QTL that contribute to ILC2 proliferation in response to aeroallergen challenge. I identified CD22, a
Siglec family receptor that inhibits B cell proliferation, as the most biologically plausible of the 72 gene
candidates. I hypothesize that CD22 is the causative gene driving the observed phenotypic differences among
the CC lines and that CD22 signaling in ILC2 inhibits their activation and proliferation. I confirmed that CD22 is
expressed on ILC2, and I observed differences in CD22 expression between CC strains that had high and low
ILC2 number in response to Alt Ex challenge. I will further test this hypothesis with two specific aims. In Aim 1,
I will perform experiments in our Alt Ex challenge model using CD22 knockout mice to investigate the effect of
gene deletion on ILC2 proliferation in vivo. Further, I will utilize a CD22-blocking antibody to define the effect of
receptor blockade on ILC2 proliferation. In Aim 2, I will continue to reduce the interval of my QTL to narrow the
list of gene candidates through the phenotyping of additional mice. I will acquire Diversity Outbred (DO) mice
and utilize my Alt Ex challenge model, increasing my fine mapping power and further defining my genes of
interest. In completing these studies, I will characterize a previously unknown regulator of allergen-induced
ILC2 number in the lung and potential therapeutic target in the treatment of allergen-exacerbated asthma.

Public health relevance
PROJECT NARRATIVE Group 2 innate lymphoid cells (ILC2) are an important driver of inflammation in allergen-exacerbated asthma, but the mechanisms that govern their activation and proliferation are poorly defined. I have used the Collaborative Cross recombinant inbred mouse panel to identify a 0.343 megabase quantitative trait locus (QTL) with 72 protein-coding genes associated with the number of lung ILC2, which is a function of their activation and proliferation in response to aeroallergen challenge. We hypothesize that CD22, a cell-surface receptor previously implicated in the inhibition of B cell proliferation, is the gene within the QTL that is responsible for driving this ILC2 phenotype, and we aim to define the ability of CD22 to inhibit ILC2 proliferation, and as a consequence, suppress innate type 2 inflammation.